Expansion of enterococcal insertion sequence elements during bacteriophage infection

PROJECT SUMMARY
Multidrug resistant enterococcal infections are a serious public health threat. The enterococci, including
Enterococcus faecalis, often harbor resistance to critical front-line drugs such as ampicillin and/or vancomycin.
Due to the increasing difficulty of treating enterococcal infections with currently available drugs, alternative
treatment options are needed. One possibility is the therapeutic use of bacterial viruses known as
bacteriophages (phages). While phage therapy has shown promise in the clinic, the emergence of phage
resistance in bacteria is a serious concern for future phage therapies. To overcome this, we need to
understand how bacteria respond to phage infection at the genetic level and the physiological consequences of
phage resistance. Past work in our lab discovered that E. faecalis isolates resistant to lytic phage 19 (phi19)
infection harbored an increased number of IS256 transposable element insertions in their genomes. These
insertions were commonly found in genes involved in phage infection, suggesting that phi19 infection
stimulates IS256 transposition to create new genetic combinations, leading to phage resistance. My
preliminary work has demonstrated that phi19 infection activates IS256 mobilization. I have found that phi19
infection increases the translation of the IS256 transposase, and that a phi19-encoded transcription factor that
resembles an anti-sigma factor, termed PAS19, increases IS256 transposase translation. This indicates that
PAS19 is responsible for activating IS256 during phi19 infection. The goals of this project are to decipher how
the E. faecalis genome evolves in response to phage driven IS256 activation, and how these downstream
effects can inform phage therapeutic strategies. To achieve these goals, I will execute two specific aims: Aim
1: Establish a mechanistic basis for phage-induced expansion of IS256 insertions in E. faecalis. Work
performed in this aim will demonstrate the functional enzymatic requirements and timing of phage mediated
IS256 activation, and will determine if this activity is broadly applicable to diverse enterococcal phages; Aim 2:
Determine how a putative phage transcription factor controls IS256 activation. PAS19, a putative
transcription factor encoded by phi19 activates IS256 expression. In this aim, I will delineate how PAS19
controls IS256 gene activation.

Public health relevance
PROJECT NARRATIVE Bacteriophage (phage) therapy has been proposed to treat intractable Enterococcus faecalis infections, but our understanding of how E. faecalis responds to phage infection is lacking. This project will investigate the genetic activation of the transposable element IS256 during phage infection, and will demonstrate how phage mediated IS256 activity alters the E. faecalis genome. This work will determine if phage therapies pose a risk for producing novel virulence or antibiotic resistance traits in the enterococci.